Monitoring response of neoadjuvant therapy in primary bladder cancer using hyperpolarized 13C MRI

PROJECT SUMMARY / ABSTRACT
The goal of this proposal titled “Monitoring response of neoadjuvant therapy in primary bladder cancer using
hyperpolarized 13C MRI” is to develop a metabolic imaging biomarker to assess neoadjuvant chemotherapy
(NAC) in muscle invasive bladder cancer (MIBC), a previously unexplored translational opportunity. This will be
accomplished by using novel quantitative hyperpolarized (HP) 13C pyruvate magnetic resonance imaging (MRI)
to assess changes in glycolysis in response to anti-cancer therapy using patient derived xenografts derived from
previously untreated tumors. NAC has been associated with a pathologic response in 40% of patients with a
complete response in up to 25%, there is significant overtreatment of non-responders. Identifying patients who
are chemosensitive would not only provide a benefit to them but would spare unnecessary toxicity and a possibly
fatal delay in radical cystectomy for patients who are chemotherapy resistant. Although cross-sectional imaging
is a cornerstone in the management of patients with MIBC at initial staging and during follow-up it has not been
applied successfully for monitoring response to NAC. Lack of specific and sensitive non-invasive means to
monitor response currently limits clinical application and value of NAC for MIBC.
In Aim 1 we will employ 6 PDX of known response to gemcitabine and cisplatin, the most commonly
prescribed NAC regimen, to evaluate the ability of quantitative imaging marker kPL, the apparent rate of
conversion of pyruvate to lactate, reflecting glycolysis, to monitor the response to said combinatorial
chemotherapy, using HP MRI. Aim 2 will lay the groundwork for providing a biological basis for the value of kPL
as an imaging biomarker of treatment response or resistance and also as a predictive marker. Additionally, we
will explore other basal metabolites and pathways that are informative of treatment effect and to develop
complimentary imaging markers in the future. Given rapidly expanding clinical studies of HP MRI, positive
preclinical results can be swiftly translated to a clinical trial.

Public health relevance
PROJECT NARRATIVE The successful outcome of this proposal is the development of much needed quantitative translational imaging biomarkers of neoadjuvant chemotherapeutic efficacy in muscle invasive bladder cancer that have been validated in clinically pertinent patient derived xenografts. The findings of this research project would pave the way for implementation of imaging markers to monitor response of muscle invasive bladder cancer to neoadjuvant chemotherapy to facilitate tailored application of toxic therapy for better tangible clinical outcomes. While this project focuses on neoadjuvant chemotherapy of cisplatin+gemcitabine combination in bladder cancer, the proposed quantitative metabolic imaging technique could ultimately benefit the clinical management of other cancers and drugs.